Genetic basis for persistence of Borrelia burgdorferi

ABSTRACT
The genetic factors required to establish a persistent infection in vertebrate hosts is one of the least
understood aspects of an infection with Borrelia burgdorferi. Multiple triggers for establishment of persistence
have been proposed. However, the lack of sensitive serologic and molecular assays has substantially impeded
work examining the biology of persistent spirochetes and their direct role in Post-Treatment Lyme Disease
Syndrome (PTLDS). We have developed two assays that overcome these major limitations and can facilitate
studies of persistent infections. The TBDCapSeq, a next generation capture sequencing assay, has a
sensitivity superior to quantitative PCR and enables B. burgdorferi genome assembly in host tissue samples.
The TBD-Serochip, a peptide array that can identify antibody responses to 170,000 linear peptides per assay,
provides unprecedented glimpses into B cell responses to the major antigens of B. burgdorferi. In this proposal
these assays will be employed in three Specific Aims that will examine molecular and genetic footprints of a
persistent B. burgdorferi infection. In Specific Aim 1, we will perform a comprehensive serologic analysis of
sera and cerebrospinal fluid from a well characterized PTLDS patient cohort. We will identify all major
immunoreactive epitopes in both specimen types. These data will be differentiated with serology data from
other non-PTLDS Lyme disease cohorts to implicate potential specific biomarkers of PTLDS. In Specific Aim 2,
we will employ the TBDCapSeq to identify molecular footprints of B. burgdorferi in the PTLDS patient cohort.
The combination of superior sensitivity of TBDCapSeq coupled with high sequencing depth will provide the
most robust molecular analysis of the link between B. burgdorferi and PTLDS. In Specific Aim 3, we will
establish an animal model for three distinct genotypes of B. burgdorferi in C3H/HeN, BALB/c and Peromyscus
leucopus mice. The capacity of each B. burgdorferi genotype for establishing persistence with and without
antibiotic treatment will be assessed and the TBDCapSeq will be used to identify genetic features unique to
persistent spirochetes. Along with genomic analysis, we will perform the first transcriptome investigation of
persistent spirochetes. Combined, these Aims will provide insight into the immune response of patients with
PTLDS and identify mechanistic triggers of spirochete persistence.

Public health relevance
PROJECT NARRATIVE A portion of Lyme disease patients continue to experience persistent symptoms even after antibiotic treatment, resulting in a condition called post-treatment Lyme disease syndrome. The cause of this syndrome is unknown but has been proposed to be caused by continuous presence of Borrelia burgdorferi, the causative Lyme disease agent. The experiments in this proposal will examine the roles of the immune response and genetics play in the development of this persistent disease and use novel state of the art tests for detection of Borrelia burgdorferi in patients with post-treatment Lyme disease syndrome.